THYROID HORMONE SECRETION AND FUNCTION OF MICROTUBLES

Limited proteolysis of rat brain tubulin yields two types of products, those derived from carboxy terminal cleavage of both subunits and those derived from a single internal cut of each subunit. These changes have major effects on polymerization of tubulin: carboxy terminal cleavage promotes polymerization whereas internal cleavage hinders assembly. The carboxy terminal-cleaved tubulin promotes the assembly of uncleaved tubulin and tissues may use this mechanism to facilitate polymerization under unfavorable conditions.